THE GENETIC AND NEUROANATOMICAL ORIGIN OF SOCIAL BEHAVIOR

THE GENETIC AND NEUROANATOMICAL ORIGIN OF SOCIAL BEHAVIOR PROJECT SUMMARY/ABSTRACT The overarching goal of this proposal is to gain insight into the plasticity of social behavior, and to identify the neuroanatomical and molecular determinants that contribute to social behavior. Social behavior is governed by both genetic and environmental factors, yet the genetic basis for normal social behavior remains poorly explored in spite of a need to better understand it for human health. This is underscored by numerous recent findings implicating dozens of susceptibility loci in autism spectrum disorders (ASDs), whose core features include marked deficits in social interaction. To gain insight into the underpinnings of social behavior, we propose to study abnormal social behavior in two mouse models of syndromic autism, the Tsc1 and Fmr1 mouse models. Single gene mutations account for a subset of syndromic ASD and mouse models of these disorders provide the opportunity to experimentally test and understand how these genes contribute to autism- like phenotypes. We hypothesize that social behavior is sensitive to the temporal requirement of either Tsc1 or Fmr1 gene function. We further hypothesize that specific neuronal populations are responsive to social stimuli, and that the loss of Tsc1 or Fmr1 may disrupt the pattern of neuronal activation in specific brain regions due to an underlying defect in common molecular targets. The Specific Aims of the proposed work are i) investigate the temporal requirement of Tsc1 and Fmr1 for normal social behavior and the plasticity of social behavior by deleteing and restoring the expression of these genes' functions in the adult mouse brain using conditionally inducible mouse models, ii) identify the neuronal populations responsive to social stimuli and examine alterations in their activity in Tsc1 and Fmr1 mouse models by analyzing the pattern of immediate early gene expression during social interaction, iii) elucidate the molecular determinants of abnormal social behavior in Tsc1 and Fmr1 mouse models using RNA sequencing, two-dimensional liquid chromatography and mass spectrometry, and protein antibody microarray platforms. Because ASDs are a prominent public health concern with a current prevalence rate of 60 cases per 10,000 children, and in some populations more than 110 cases per 10,000 children, the proposed work is designed to determine if social behavior can be modified, and possibly corrected, in neuropsychiatric conditions during the adult stage of life. The research aims will also inform us of the neuroanatomical determinants and molecular targets that may be critical in the manifestation of social behavior phenotypes. Together, our findings will provide the foundation for future work designed to improve social behavior phenotypes in humans by either genetic or pharmacological means.

Public health relevance
PROJECT NARRATIVE ASDs constitute a prevalent and devastating group of neuropsychiatric disorders affecting as many as 1:100 - 1:150 children. The proposed work will determine if social behavior deficits, such as those characteristic of ASDs, are reversible in adulthood, and will identify the neuroanatomical and molecular pathways that determine healthy social interactions. Defining the fundamental neuronal and molecular changes related to social behavior impairments has far-reaching benefits for human health, given that ASDs are a rising, prominent public health concern. __SpecificAimsTextDelimiter__ THE GENETIC AND NEUROANATOMICAL ORIGIN OF SOCIAL BEHAVIOR SPECIFIC AIMS The overarching goal of this proposal is to gain insight into the plasticity of social behavior, and to identify the neuroanatomical and molecular determinants that contribute to social behavior. Social behavior is governed by both genetic and environmental factors, yet the genetic basis for normal social behavior remains poorly explored despite the need to better understand it for human health. This is underscored by numerous recent findings implicating dozens of susceptibility loci in autism spectrum disorders (ASDs)1-4. ASDs, whose core features include marked deficits in social interaction, are a prominent public health concern with a current prevalence rate of 60 cases per 10,000 children5, and in some populations more than 110 cases per 10,000 children6,7. Due to the genetically heterogeneous nature of ASD, there are many challenges in elucidating the pathoetiology of ASD-related social behavior abnormalities. One major challenge, for example, is to understand the plasticity of social behavior. In contrast to heightened anxiety, a co-morbid symptom of ASD that can be influenced and often determined early during infancy8, it is unclear whether social behavior is developmentally defined, or sensitive to altered gene function during adulthood. Furthermore, the overlapping clinical features of ASD may suggest a common underlying neural dysfunction, yet little is known about the key neuroanatomical and molecular components that contribute to neural processing of information during social interaction. Therefore, to gain insight into the underpinnings of social behavior, we propose to study abnormal social behavior in two mouse models of syndromic autism, the Tsc1 and Fmr1 mouse models. Single gene mutations account for a subset of syndromic ASD9 and mouse models of these disorders provide the opportunity to experimentally test and understand how these genes contribute to autism-like phenotypes. We hypothesize that social behavior is sensitive to the temporal requirement of either Tsc1 or Fmr1 gene function. We further hypothesize that specific neuronal populations are responsive to social stimuli, and that the loss of Tsc1 or Fmr1 may disrupt the pattern of neuronal activation in specific brain regions due to an underlying defect in common molecular targets. Specific Aim 1. Investigate the temporal requirement of Tsc1 and Fmr1 for normal social behavior and the plasticity of social behavior. Both humans and mice lacking functional copies of Tsc1 and Fmr1 throughout life display social behavior deficits. One interpretation of these data is that these genes are important early in development to establish the proper neural activity responsible for normal social behavior in adulthood; this would suggest that the social behavior is hard-wired. An alternative explanation, however, is that there is a post-natal requirement for these genes for normal social behavior, implying that social behavior is plastic and influenced by genetic factors post-natally. Whether the impaired social behavior results because these genes are important in early development, are critical for normal social behavior in the adult, or both is currently unknown. To test the hypothesis that the manifestation of normal social behavior is sensitive to the temporal requirement of syndromic autism-causing genes in adult animals, we will generate tamoxifen- inducible, forebrain-specific conditional knock-out Tsc1 and Fmr1 mice to study the post-natal effects of deleting these genes on social behavior using three behavioral test paradigms. In addition, we will generate tamoxifen-inducible, forebrain-specific conditional restoration Tsc1 and Fmr1 animals to test whether social behavior deficits can be rescued in adult animals lacking expression of these genes early in development. Specific Aim 2. Identify the neuronal populations responsive to social stimuli and examine alterations in their activity in Tsc1 and Fmr1 mouse models. Abnormalities in social behavior may be due in part to alterations in neural activity in discrete neuronal populations responsive to social stimuli. As a first step to test this hypothesis, we will map the neuroanatomical regions responsive to social stimuli by analyzing the transcript expression of immediate early genes in serial brain sections of wild-type mice at different timepoints during social behavior tests. By establishing the pattern of neurons activated in response to social stimuli in wild-type mice, we can test the hypothesis that the loss of Tsc1 or Fmr1 disrupts the pattern of neuronal activation associated with normal social behavior. Specific Aim 3. Elucidate the molecular determinants of abnormal social behavior in Tsc1 and Fmr1 mouse models. One shared feature among syndromic ASD is a deficit in social interaction, yet the mechanism to explain the manifestation of this phenotype among genetically distinct disorders remains poorly understood. Evidence demonstrates that the mTOR pathway, the downstream target of TSC1, is up-regulated in Fmr1-null animals10, suggesting that common molecular targets may be perturbed in these two particular mouse models, and perhaps in the human conditions. Because of this potential functional link, we will analyze the transcriptome and proteome of i) a brain region that responds aberrantly to social stimuli in Tsc1 and Fmr1 mice, and ii) the amygdala, which has role in aspects of social behavior. These studies will allow us to test the hypothesis that common molecular determinants of social behavior are altered between the animal models.